Biological And Structural Diversity Of Bacterial Type IV Secretion Systems

Project Summary for NOT-GM-21-028 (PA-20-272) supplemental application included in Research Strategy Section.

Public health relevance
Project Narrative not required for NOT-GM-21-028 (PA-20-272) supplemental application.